Effects of Environmental Estrogen Exposure on Spontaneous Copy Number Variation

Project Summary/Abstract My long-term goal is to obtain a faculty position at a research university so that I can continue to independently investigate how environmental estrogens affect humans. The short-term goal is to determine if environmental estrogens are able to alter vertebrate genomes. My immediate goal is to develop the skills and training necessary, primarily array comparative genomic hybridization (CGH) and morpholino injection, to develop an independent research program using these approaches and skills. While the use of CGH is not a new technique, its use as a method of determining whether genomic changes are present between normal individuals has only recently been used. Dr. Lee pioneered this technique and under his mentorship at Brigham and Women's Hospital, and the highly collaborative, educational environment at Harvard Medical School, I will be allowed to learn and master its use. I fully believe that this is an ideal environment to advance my career and use this Award to become and independent investigator. Environmental estrogens are chemicals in the environment that alter or interact with native estrogen. These chemicals include a broad array of compounds from pesticides such as DDT, plasticizers such as bisphenol A and pharmaceuticals such as human birth control pills (17α-ethynylestradiol; EE2). Despite their relevance in the environment and known and suspected effects on humans and animals, no studies have been done to determine whether these chemicals induce genomic level changes. The purpose of this study is to determine whether environmentally relevant concentrations of EE2 are able to induce genomic level changes using the model organism zebrafish. Genomic changes will be determined as the induction of spontaneous, or de novo, changes in copy number variation. Additional studies will be performed to determine how spontaneous CNVs arise and evaluate how EE2 alters or impairs the DNA repair mechanisms that are designed to prevent such changes.

Public health relevance
Project Narrative Environmental estrogens are found in surface and ground waters worldwide and are known to have significant affects on wildlife and potentially human health. Whether or not these chemicals can alter vertebrate genomes is currently unknown. This project will determine if these chemicals can alter vertebrate genomes and have the potential to impact human health through the initiation and progression of disease. __SpecificAimsTextDelimiter__ Specific Aims Does environmental exposure of endocrine disrupting chemicals increase disease risk through spontaneous genome changes in copy number variation? This question must be addressed given the increased knowledge that spontaneous, or de novo, changes in genomic copy number variation (CNV) contribute to disease. With endocrine disrupting chemicals ubiquitously present in the environment we must determine whether such chemicals induce de novo CNV changes within human genomes. Endocrine disrupting chemicals comprise several classes of chemicals with those exhibiting an estrogenic mode of action (i.e., environmental estrogens) being of major concern. While human health impacts resulting from environmental estrogens are controversial, mounting evidence indicates that increased exposure of these chemicals in industrialized countries has resulted in decreased sperm counts, testicular cancers and other congenital anomalies. Animal model studies directly link environmental estrogen exposure to aneuploidy germ cells, decreases DNA repair mechanisms and altered epigenetic patterns. These changes result in modified gene expression, increased cancer susceptibility, congenital aberrations and/or diminished reproductive capacity. Despite animal model findings and human study results, no genomic scale analyses have been performed to establish whether environmental estrogens can inducing de novo CNV formation. This project will evaluate the hypothesis that "The Environmental Estrogen 17α-ethynylestradiol Alters Vertebrate Genomes Through De Novo Copy Number Variation Changes". The following Specific Aims are proposed for this project: Aim 1: Copy Number Variation in Zebrafish Estimate copy number variation in zebrafish using comparative genomic hybridization, qPCR and DNA sequencing. 1A: Background Copy Number Variation: Determine the level of genomic copy number variation in two zebrafish strains to establish background levels. 1B: De Novo Copy Number Variation Formation: Establish the frequency of de novo CNV formation over five generations of full sib matings. Aim 2: Genomic Effects of the Environmental Estrogen Exposure in Zebrafish Determine whether 17α-ethynylestradiol induced genomic changes. 2A: Large scale chromosomal effects: Do high level exposures increase sperm aneuploidy. 2B: Copy Number Variation: Evaluate CNV patterns for de novo changes. Aim 3: Mechanisms of CNV Formation. Establish the effects of known proteins required for DNA replication and repair on CNV formation through the use of morpholino injection. The proposed research builds upon Dr. Brown's background in genetics, development and reproductive toxicology, specifically research in genetic effects of environmental estrogens. The mentored phase will occur at Harvard Medical School/Brigham and Women's Hospital under the co-direction of Dr. Charles Lee, a leader in the field of CNV, Dr. Joan V. Ruderman, cell cycle regulation and environmental estrogens expert and Dr. Leonard Zon, zebrafish genomics expert. The academic environment provides access to recognized leaders across additional disciplines' including human genetics and cancer. Through completion of the proposed mentored research and establishment of new scientific collaborations, Dr. Brown will develop a comprehensive understanding of 17α-ethynylestradiol's effect on de novo CNV formation. This knowledge will undoubtedly lead to exciting new opportunities regarding the consequences of de novo CNV formation in human disease occurrence and progression and provide ample intellectual content to secure independent R01 funding.